Core Grant for Vision Research-Morphology Module Core

Morphology Project Summary/Abstract
The Morphology Module has three primary functions. First, the module provides technical assistance for light,
electron, and confocal microscopy. Services include paraffin, methacrylate, epoxy, epon, and frozen
sectioning; and complete transmission electron microscopy and scanning electron microscopy services.
Second, the module is an equipment resource, housing a laser microdissection system, two confocal
microscopes including a new inverted confocal system, automated histology and electron microscopy tissue
processors, ultramicrotomes, cryostats, various fluorescence and phase microscopes, computers and printers
to process digital images. Third, the module provides consultation for various histology, electron microscopy
and microscopy procedures and troubleshooting, and training on all microscopes.